Administrative Core

Administrative Core
SUMMARY
The overall goal of the Administrative Core is to provide administrative support to ensure the
successful accomplishment of the scientific and public outreach goals of our ICEMR Center.
The goal of this ICEMR is to assess over time the impact of environmental modifications such
as the construction of dams, irrigation and shifting agricultural practices on malaria
epidemiology, vector biology and pathogenesis in Kenya and Ethiopia. This Center involves a
considerable number of investigators based at institutions in malaria endemic and malaria
non-endemic regions of the world. A well-developed administrative plan is essential for the
success of this Center that involves extensive international collaboration and multiple
investigators from the US, Kenya, Ethiopia and Australia. Thus, this Administrative Core is
designed to manage, coordinate, and supervise the entire range of Center activities, monitor
progress, and ensure that the milestones defined by each project are being met and are
implemented effectively within the proposed timelines. This Core has four major goals: 1) to
coordinate, supervise and manage the research activities of the Center to ensure the
accomplishment of the scientific goals of our Center; 2) to provide financial management for
the Center to ensure fiscal rules of the US federal government and NIH are followed,
including the effective management of subcontracts at participating domestic and
international institutions; 3) to foster outreach activities to promote collaborations with the
Ministries of Health of Kenya and Ethiopia and other ICEMR centers based in other malaria
endemic regions; and 4) to organize and coordinate training of students, junior scientists and
project scientists in data management, and techniques in biostatistics, malaria epidemiology,
vector biology and immunology. The well-developed management plan, together with our
previous track records in ICEMR project administration, will facilitate the multidisciplinary
research of this Center, student training and scientific collaborations.
.